COVID-19 Lung Microvascular and Parenchymal Sequelae (Lung-MaPS)

The long-term health impact of COVID-19 remains uncertain. We are already providing post-hospitalization
care for thousands of COVID-19 survivors at Columbia University Irving Medical Center (CUIMC) in New York
City. This study is designed to help our and other medical centers care for COVID-19 survivors by using gold-
standard imaging approaches to describe the major sequelae of severe COVID-19. The possibility of
significant vascular and parenchymal sequelae of severe COVID-19 is suggested by the prominent Alverolar-
arterial gradients observed clinically, plus histopathology confirming substantial endothelial and epithelial
damage. Nonetheless, precise assessments of vascular and parenchymal sequelae in vivo have been limited,
especially for the vasculature, and long-term follow-up to assess recovery or progression is lacking. Our
investigative team has developed and refined a dual-energy computed tomography (CT) protocol to provide
direct measures of the pulmonary vasculature, including pulmonary parenchymal perfused blood volume
(PBV); and, detailed phenotyping of the parenchyma, including ground glass opacity (GGO) textures, which we
have identified by an adaptive multiple features model (AMFM) approach in preliminary work among COVID-19
survivors. In multiethnic cohort studies, we have associated these CT measures with development and
progression of chronic lung diseases. To strengthen our investigation into potential microvascular mechanisms
of COVID-19 lung injury, this application will also test if PBV is associated with biomarkers of inflammation,
hypercoagulability, and complement activation. We will randomly sample 200 adults without a prior diagnosis
of chronic lung disease who were hospitalized for COVID-19 at CUIMC and did not require intubation, plus 100
seronegative controls matched on age, sex, race, ethnicity, body mass index, and neighborhood. All
participants will undergo contrast-enhanced dual-energy CT, diffusing capacity of the lung for carbon
monoxide, spirometry, questionnaires, and phlebotomy for SARS-CoV-2 antibodies and biomarkers. These
measures will be performed 3-12 months and 27-36 months post-COVID hospital discharge to accomplish
three specific aims. Aim 1 is to define lung microvascular sequelae of COVID-19. We hypothesize that PBV in
COVID-19 survivors will be lower and more heterogeneous, and that these abnormalities will be associated
with levels of IL-6, CRP, d-dimer, C5a, MBL, and MASP-2. Aim 2 is to define lung parenchymal sequelae of
COVID-19. We hypothesize that there will be greater GGO texture patterns in COVID-19 survivors. Aim 3 is to
explore if COVID-related differences in lung structure and procoagulant biomarkers are maintained up to 3
years after acute illness. We hypothesize that two years following the baseline study visit, parenchymal and
biomarker abnormalities will normalize, but vascular abnormalities will progress. Accomplishment of the Aims
will guide post-COVID care and risk stratification, suggest targets for therapeutic interventions, and inform
policies for risk mitigation and public health in the COVID-19 era.

Public health relevance
Project Narrative Leveraging expertise in innovative lung imaging and growing experience in COVID-19 clinical care at Columbia University Irving Medical Center (CUIMC) in New York City, we propose to apply state-of-the-art dual energy computed tomography to define the lung vasculature and parenchyma in 200 patients hospitalized for COVID- 19 at CUIMC and 100 matched controls. To strengthen our investigation into microvascular mechanisms of COVID-19 lung injury, we will correlate imaging findings at 3-12 months and 27-36 months post-COVID hospital discharge with biomarkers of inflammation, hypercoagulability, and complement activation. This will provide important insights on the development, progression, and prognosis of post-COVID chronic lung disease that will be suitable to guide post-COVID care and risk stratification, suggest targets for therapeutic interventions, and inform policies for risk mitigation and public health in the COVID-19 era.